UM LAPs -UG1 Grant

PARENT PROJECT SUMMARY
The University of Michigan (UM), inclusive of its Comprehensive Cancer Center (UMCCC) and Medical School
Departments, requests this UG1 award as an NCI National Clinical Trials Network Lead Academic Participating
Site (NCTN LAPS-UG1). We view this opportunity as an important component of a large cancer research effort
at our institution. We remain committed to the concept that multi-institutional collaboration is essential to the
advancement of cancer treatment. Our goal as a LAPS site is to make significant scientific, leadership,
administrative and patient data contributions to the NCTN effort to study and improve cancer therapy. The
NCTN process involves the development and conduct of purposeful clinical trials, adoption of uniform toxicity
and response criteria, collection of patient data, and results reporting. NCTN Group research is the only setting
in which sophisticated concepts of combined modality and interdisciplinary therapy as well as adjuvant
therapies can be properly evaluated. NCTN clinical research has also provided an improved understanding of
the important relationships between prognostic factors, therapy and patient outcomes that could not have been
obtained otherwise.

Public health relevance
PARENT PROJECT NARRATIVE The University of Michigan participation as a Lead Academic Participating site (LAPS) is interdisciplinary with clinical investigators and basic research associates involved in the National Clinical Trials Network (NCTN) activities and membership in three of the four adult Cooperative Groups. This involvement in NCTN research is characterized by scientific, leadership and administrative contributions, robust accrual to NCTN trials, quality data management and protocol compliance.